IAFF HazMat Training at DOE Nuclear Sites

Project Summary/Abstract:
The International Association of Fire Fighters (IAFF) will continue its worker health and safety
training program to prepare workers, including firefighters and emergency response personnel,
within a 150-mile radius of DOE weapons facilities to respond to complex emergencies, aiming to
prevent work-related harm and enhance health and safety. Through this collaboration, the IAFF
will deliver established, high-quality training programs, including the HazMat Technician,
Confined Space Rescue, HazMat Operations, and the cutting-edge Responding to Renewable
Energy course, currently in development in conjunction with the DOE Office of Energy Efficiency
& Renewable Energy. The IAFF has a proven track record of developing, updating, and delivering
emergency responder training programs, evidenced by successful impact stories, excellent survey
feedback, and repeated positive third-party reviews.
IAFF training will be accessible to workers who respond to chemical release emergencies at DOE
facilities, including firefighters, EMS, emergency management, public health officials, facility
managers (labor and management), law enforcement, other emergency response personnel, and
local community partners. Through this continued cooperative agreement, the IAFF will:
• Deliver a minimum of 12 HazMat Technician courses, 12 Confined Space Rescue courses, five
HazMat Operations courses, and five Responding to Renewable Energy Emergencies courses
annually, resulting in at least 34 classes each year, training 850 workers. Over a five-year
period, the IAFF will conduct a minimum of 170 classes, training 4,250 workers.
• Use a robust network, including GIS software, social media, and partnerships with public and
private sectors to reach firefighters, EMS, emergency management, public health officials,
facility managers (labor and management), law enforcement, and other emergency response
personnel who are likely to response to a chemical emergency within a 150-mile radius of the
DOE facility.
• Utilize innovative evaluation protocols including Kirkpatrick levels of evaluation to
demonstrate training effectiveness and exceed the NIEHS Minimum Training Criteria using
third-party evaluators to sample trainees, gather feedback, apply data analysis, and logic
models to assess the efficacy.

Public health relevance
Project Narrative The IAFF has partnered with the NIEHS Worker Training Program since 1995, delivering 649 classes and training 13,943 workers, including firefighters, at DOE nuclear weapons complexes to prevent work-related harm and enhance safety. With the increasing complexity of DOE facilities, workers and responders face significant challenges such as occupational cancer and potential rising occurrences of hazardous chemical releases. The IAFF remains determined to address these issues through comprehensive and advanced training, innovative technology, and stringent program evaluation, ensuring all DOE workers, including firefighters, first responders, and other emergency response personnel, are thoroughly prepared to safely and efficiently mitigate emergency incidents.